Core A: Administration

PROJECT SUMMARY/ABSTRACT
The purpose of this core is to facilitate communication between the investigators, collaborators, and advisors of
the Program Project, and to provide oversight for all scientific activities, including routine assessment of progress
toward the Program’s specific aims. This effort includes organizing the regular meetings of the investigators and
advisors of the Program Project. The Administrative Core provides financial management and oversight of
compliance with NIH regulations, as well as general administrative services, for all research projects and core
units of the Program Project.

Public health relevance
PROJECT NARRATIVE By providing centralized essential administrative support and budgetary oversight, this Core assists all Projects and Cores on this Program Project Grant in achieving their overall goal of developing improved therapies for patients with hematological malignancies, focusing primarily on adoptive cell therapy and hematopoietic cell transplantation.